Ca2+-Dependent Block by Mematine and Selective Inhibition of Overactive NMDA Receptors

PROJECT SUMMARY/ABSTRACT
The research proposed here addresses drugs that inhibit N-methyl-D-aspartate receptors (NMDARs),
which are 4-subunit ionotropic glutamate receptors found at most vertebrate excitatory synapses. NMDARs are
involved in a remarkable range of both nervous system physiology and nervous system disorders. Ca2+ influx
through NMDARs is a signal of central importance to synaptic plasticity throughout the brain. Excessive NMDAR-
mediated Ca2+ influx, however, has been linked to many nervous system disorders, including Alzheimer's
disease and other neurodegenerative diseases, stroke, and traumatic brain injury. It therefore would appear that
NMDAR inhibitors should have wide therapeutic potential. However, most NMDAR inhibitors have been
unsuccessful in clinical trials, probably because widespread inhibition of NMDARs has multiple unacceptable
side effects. Memantine, however, is an NMDAR channel blocking antagonist that is one of the few drugs
approved for treatment of Alzheimer's disease. The reasons why memantine is both effective and unusually well-
tolerated remain under debate. An explanation is suggested by the recent observation that memantine acts to
stabilizes a Ca2+-dependent desensitized state of NMDARs while blocking the NMDAR channel. As a result,
memantine preferentially inhibits NMDARs that are exposed to high intracellular Ca2+ concentrations, which are
the NMDARs most likely to mediate pathological Ca2+ influx. Thus, designing drugs that, like memantine, inhibit
NMDARs more effectively as intracellular Ca2+ rises offers a promising new strategy for developing especially
effective therapeutic agents. The goals of the proposed research are to deepen understanding of interactions
between memantine and NMDARs, including of NMDARs composed of three different types of subunits, which
are widely expressed by challenging to study. Binding sites on NMDARs for memantine and other channel
blockers will be identified and distinguished using an advanced combination of computational chemical modeling
and physiological study of wild-type and mutant NMDARs. Guided by computational models, new compounds
designed to interact with NMDARs in a strongly Ca2+-dependent manner will be synthesized and used to deepen
understanding of channel blocker-NMDAR interactions. The dependence on intracellular Ca2+ of inhibition by
memantine and other channel blockers will be examined using neuronal preparations, and the Ca2+ dependence
of their neuroprotective properties evaluated. New channel blockers with enhanced dependence on intracellular
Ca2+ will serve as lead compounds for future development of more effective treatments for Alzheimer's disease
and related neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE In the proposed research we will examine the mechanisms by which memantine, one of the few drugs approved for treatment of Alzheimer's disease, protects nerve cells from damage. We will study how memantine works physiologically, use computer modeling and medicinal chemistry to design and synthesize new neuroprotective drugs, and use the new drugs to deepen understanding of neuroprotective strategies. The proposed research will examine a new approach for developing therapeutic drugs and will produce lead compounds for future development of improved medications to treat Alzheimer's disease.